The Role of Pericytes in Brain Hypoperfusion in Alzheimer's Disease Development

PROJECT SUMMARY/ABSTRACT
Vascular dysfunction, such as decreases in cerebral blood flow (CBF) and disruption of the blood brain barrier
(BBB) are early symptoms of Alzheimer’s disease (AD) and could contribute to AD onset and progression. In the
brain, specialized cells called pericytes are integral to proper vascular function, as they play a major role in
regulating CBF and maintaining BBB integrity. However, the processes that govern pericyte dysfunction and the
role of pericytes in decreases of CBF in AD development have not been fully elucidated. Our previous studies
have demonstrated that increases in the transcription factor Fli-1 are associated with pericyte dysfunction and
viability via up-regulation of caspase-1 expression. Our preliminary data demonstrated that Fli-1 levels were
higher in the hippocampus and superior temporal gyrus regions of brain tissue from AD patients compared to
controls. Pericytes undergo apoptosis in the hippocampus of AD patients, and pericyte Fli-1 levels were
increased in AD patients. In addition, TNF and aggregated amyloid- induced Fli-1 expression in cultured
human brain pericytes. Furthermore, amyloid- induced pericyte apoptosis, as evidenced by decreased pericyte
viability, increased TUNEL positive cells, and increased expression of apoptosis marker caspase-3. Knockdown
of Fli-1 with antisense oligonucleotide Gapmers suppressed amyloid--induced pericyte death, apoptosis, and
caspase-3 levels. Thus, increased Fli-1 levels in AD patients may lead to pericyte loss. To determine the cause-
effect relationship between increased Fli-1 and AD development, we conducted studies in the 5xFAD mouse
model. Fli-1 levels were higher in the hippocampus in 5xFAD mice and corresponded with spatial learning and
memory impairment in Novel Object Recognition and Morris Water Maze tests. Injection of Fli-1 Gapmer into the
hippocampus significantly decreased Fli-1 and inflammatory mediator levels, mitigated pericye loss and vascular
leakage, suppressed adhesion molecule levels, reduced A deposition, and ameliorated spatial learning and
memory impairment. These data provide the first evidence that increased Fli-1 levels contribute to AD
development. We hypothesize that the transcription factor Fli-1 elevation in Alzheimer's disease leads to
pericyte dysfunction and brain hypoperfusion. Three specific aims are proposed to address this hypothesis:
Aim 1: Determine how Fli-1 regulates pericyte and neurovascular cell dysfunction in a mouse AD model. Aim 2:
Elucidate the mechanisms by which pericyte dysfunction results in brain hypoperfusion and cognitive impairment
in a mouse AD model. Aim 3: Test the therapeutic potential of intrathecal administration of Fli-1 Gapmers in
mouse AD models. The successful completion of the proposed studies will result in a better understanding of
the role of Fli-1 in regulating pericyte dysfunction in AD and the development of a novel treatment strategy for
AD.

Public health relevance
PROJECT NARRATIVE Pericyte dysfunction results in decreases in cerebral blood flow and disruption of the blood brain barrier, which contribute to Alzheimer’s disease (AD) development. The goals of this proposal are to gain a deep understanding of the role of Fli-1 in regulating pericyte dysfunction in AD and to develop a novel treatment strategy for AD.